Candida albicans Target of Rapamycin in oxidative stress responses

Abstract
The goal of this proposal is to examine the role of Candida albicans Tor1 kinase and specifically, its least-
conserved domain, N-terminal HEAT repeats, in enabling this fungal pathogen to withstand oxidative stress
imposed by the host immune system. We showed that C. albicans cells lacking Tor1 N-terminal HEAT
repeats, which are protein-protein interaction domains, are exquisitely hypersensitive to oxidative stress.
They also dysregulate dedicated oxidative stress management systems of the fungus, and their metabolic
output of intermediates required in redox homeostasis is defective. Tor1 point mutants that we recently
engineered, show that these severe defects are not attributable to simple hypo- or hyperactivity of the
kinase. Instead, these cells’ oxidative stress management defects appear to relate to functions residing in
the N-terminal HEAT repeats. Notably, we found a core enzyme of C. albicans redox homeostasis, that is
structurally and functionally completely different than its human counterpart, to be dysregulated in cells
lacking Tor1 N-terminal HEAT repeats. We also found that depletion of this enzyme leads to starkly
decreased TORC1 signaling even in conditions of ample nutrients and absent stress. We propose to define
the interactions between Tor1 and its N-terminal HEAT repeats with dedicated C. albicans oxidative stress
management systems.

Public health relevance
Narrative Growth and stress resistance of the common human fungal pathogen, Candida albicans, is regulated by the essential Target of Rapamycin Kinase 1 (Tor1). We will characterize the role of this cardinal regulator in oxidative stress resistance, as it interacts with other proteins the fungus uses to survive oxidative stress imposed by the human immune system.